Mechanisms controlling the efficiency of hemostatic vitamin K-dependent protein activation

Project Summary
Dietary vitamin K is used in virtually all tissues to convert clusters of Glus to gamma-carboxylated Glus (Glas)
in vitamin K-dependent (VKD) proteins. Carboxylation activates VKD proteins by generating a calcium-binding
module required for their function. The first VKD proteins identified were coagulation factors, which also have
signaling roles that impact other physiologies (e.g. inflammation). Additional extrahepatic VKD proteins also
regulate calcification, growth control, apoptosis and signal transduction. Defining Gla formation is therefore
essential for understanding the impact of VKD proteins on human health and disease. A single gamma-
glutamyl carboxylase generates Gla by oxygenating vitamin K hydroquinone (KH2) to an epoxide (KO). KO is
then recycled by the vitamin K oxidoreductase (VKORC1) in two steps: from epoxide to vitamin K quinone, and
then quinone to hydroquinone. We showed that VKORC1 forms a dimer that is important in accomplishing
these two reactions. VKORC1 is the target of warfarin, a drug used by millions of people worldwide to control
blood clotting, for example with mechanical heart valves. We made the surprising discovery that warfarin
uncouples normal KO reduction, necessitating a second reductase during therapy to generate KH2 for VKD
protein carboxylation. The results are highly significant because extrahepatic VKD proteins may be poorly
carboxylated and dysfunctional if the second reductase is not ubiquitously expressed like VKORC1.
We showed that a VKORC1 dimer is important to KO recycling to KH2, and our recent preliminary data
suggest that VKORC1 and the carboxylase form a complex. We hypothesize that vitamin K sequestration by
these protein-protein interactions promotes efficient vitamin K recycling. Some VKORC1 mutations cause
warfarin resistance, i.e. the requirement for higher warfarin doses to manage hemostasis, and we hypothesize
that these mutations disrupt dimer integrity. Naturally occurring carboxylase mutations cause severe bleeding,
and some mutants appear to be defective in VKORC1-carboxylase interaction. The aims in this application will
define the protein-protein interactions that make VKD protein carboxylation so efficient and what role they play
in warfarin inhibition. Aim 1 will test whether vitamin K sequestration mediates VKORC1 reduction by
identifying VKORC1 dimerization domains and testing their function in CRISPR/Cas9 edited cell lines deleted
for endogenous VKORC1. Aim 2 will test the importance of VKORC1-carboxylase association in vitamin K
recycling by determining whether human carboxylase mutations that cause severe bleeding disrupt normal
vitamin K recycling, and by studying the efficiency of vitamin K recycling in a carboxylase mutant mouse model.
Aim 3 will test the hypothesis that a quinone reductase distinct from VKORC1 supports VKD carboxylation
during warfarin therapy by testing candidate reductases we have identified in cell line models. Successful
completion of these aims will reveal the mechanisms of efficient VKD protein carboxylation, and provide
important new information for warfarin therapy.

Public health relevance
Project Narrative Low amounts of vitamin K in the diet are converted to an activated form in the body that is used for blood clotting by two proteins called VKORC1 and the carboxylase. VKORC1 is inhibited by the drug warfarin, which is used by millions of people worldwide to control blood clotting, for example with mechanical heart valves, while the carboxylase modifies vitamin K-dependent proteins to activate them for roles in blood coagulation, bone development, cell growth and embryonic development. Determining how VKORC1 and the carboxylase function has important ramifications for understanding these aspects of human health and producing activated vitamin K-dependent proteins as potential therapeutic drugs.